An Internet of Things Automated Cognitive Behavioral Therapy for Insomnia that Improves Cognition in Older Adults

Abstract and Summary
We will address the public health issues of insomnia and Alzheimer’s Disease (AD), which costs the US
healthcare system >$400 billion/year, with an additional ~$411 billion/year cost in lost productivity. Due to the
strong role that sleep deprivation and insufficient slow wave sleep (SWS) play in conversion to mild cognitive
impairment (MCI) and AD, the proposed business development research will address both public health
issues. Previously, we showed that our patented technology could accurately measure sleep stages; and we
successfully completed a randomized controlled trial (RCT) on 60–90-year old’s (n = 54) showing that we could
augment conventional Cognitive Behavioral Therapy for Insomnia (CBTi). Our technology resulted in more
remission to insomnia than conventional care when administered by a clinician. We are now seeking funding to
conduct a validation study of a fully automated version of the technology that increases adherence to CBTi and
is applicable to an older and/or non-adherent population. Called SleepSpace AI, the new system will improve
adherence to CBTi using cues delivered via an unlocked smart phone, smart light bulbs, and sounds emitted
from the phone. It will also provide personalized feedback based on user data to augment recommended sleep
schedules, be easily accessible to deliver weekly interactive modules with a customized AI avatar, will be fully
controllable via voice commands, and uniquely, it will focus on improving sleep quality and sleep amount. We
will demonstrate the technology’s feasibility at improving sleep quality and cognition using a larger sample size
and upgraded study design that includes sound and light sham conditions and active controls from the market
leader in digital therapeutics. We will internally test this modified system and seek pre-submission feedback
from the FDA (Specific Aim 1). We will then conduct an RCT on 180 participants aged 65+ years old who
self-report moderate to severe insomnia based on an Insomnia Severity Index (ISI) score >= 15. Participants
will commit to engage in an 11-week study that will include one-week baseline where sleep and cognition are
evaluated, followed by random assignment to six-weeks of: 1) SleepSpace AI, 2) Competitor Digital
Therapeutic (i.e. Somryst), and 3) Sleep Hygiene Control. (Specific Aim 2). Treatment will be followed by a
one-week and four-week assessment of sleep and cognition. We hypothesize that SleepSpace AI will be
superior to the leading competitor and Sleep Hygiene Control, as measured by the ISI (primary outcome). We
also hypothesize that it will be superior to both conditions on sleep quality (SWS), sleep amount, survey
assessments of cognition, and objective measures of cognition (secondary outcomes). A more effective, fully
automated, digital CBTi that integrates with IoT devices will result in a safe, easy-to-use, effective, and
affordable treatment for insomnia that could improve cognition in older adults. If proven effective in the planned
study, this scalable technology can serve as a primary prevention strategy for MCI/ADRD, with the potential to
be generalized to an MCI population that may typically struggle with following cumbersome CBTi directives.

Public health relevance
Project Narrative We will refine and evaluate an innovative smart-phone and Internet of Things (IoT) technology that improves sleep quality, treats insomnia, and enhances cognition in a non-pharmacological, safe, easy-to-use, and affordable way. In an 11-week Randomized Controlled Trial (RCT) on 180 participants aged 65+ who report moderate to severe insomnia, we will demonstrate improved sleep quality outcomes compared to the standard of care. We will also evaluate if the technology is an effective primary prevention strategy for Alzheimer’s Disease and Related Dementias (ADRD) by testing if improvements in sleep quality (i.e. slow wave sleep) mediate better cognition on a cognitive battery sensitive to Mild Cognitive Impairment (MCI) and ADRD.